Growing the Genetics of Addiction Workforce with URM Faculty-Student Research Experiences

PROJECT SUMMARY
The Jackson Laboratory (JAX) will provide a unique research and training experience designed to encourage
and assist members of groups that are under-represented in the biomedical and behavioral sciences to pursue
or advance research or science-related careers in addiction-related areas. The long-term goal is to increase the
diversity of next-generation scientists that can use cutting edge genetics and genomics techniques to study
addiction. To achieve this goal, trainee recruitment efforts will target institutions serving significant
underrepresented minority (URM) populations and faculty who themselves are URM. This training program
consist of two components. To begin, participants will first complete a customized, virtual mentored course
designed to deliver foundational skills and knowledge in mammalian and systems genetics of addiction. The
virtual course will combine newly-derived content combined with material derived from several of JAX's signature
courses including the McKusick Human and Mammalian Genetics Short Course, and the Short Course on the
Genetics of Addiction, and from established JAX online educational modules including The Basics of Mouse
Genetics, and Complex Traits. Then, a subset of course participants will be invited to return to JAX with 2 trainees
(post-doctoral, graduate or undergraduate) for an extended summer research experience mentored by hosting
JAX faculty. Faculty-trainee teams will be hosted at JAX by program mentors, where they will make use of JAXs
advanced research resources to learn techniques needed to augment their research into addiction related
phenomena through the incorporation of mammalian genetics and genomics. They will return to their home
institutions with knowledge, skills, data and resources to support follow-on research, presentations, publications
and grant applications. This model will foster the career development of URM faculty as well as both the
participating young scientist-trainees and the future trainees of the URM faculty member. The program is
designed to achieve the following Specific Aims: 1) Provide foundational education in mammalian genetics and
systems genetics of addiction through virtual, mentored instruction. 2) Engage diverse faculty and student teams
in summer mentored research projects utilizing advanced methods and resources for addiction genetics. 3)
Recruit individuals from underrepresented minority groups to participate in the virtual course, mentored research
experiences, and career development skills training. Impact: Successful completion of these aims will result in
an expanded number of addiction researchers from URM groups who are actively working with model organism
genetics and genomics to understand and characterize mechanisms of addiction related behavior. Educational
materials will be made broadly available, and a select group of investigators will advance to develop specific
genetic and genomic research programs with support in the use of emerging technologies in these fields. The
effectiveness of this novel program will be evaluated and if successful, may be used as a model for expanded
deployment in other research fields or institutions.

Public health relevance
PROJECT NARRATIVE Addiction is a significant public health problem in the US that has a disproportionately large effect on underrepresented minority (URM) communities, and the members of such communities are much less likely to be a part of the biological research community that is tackling these challenges. The reasons for this are documented and varied, but one contributor is a lack of URM access to world-class research resources, technologies and training and career mentoring needed to launch innovative new research programs in addiction biology. To begin to bring the needed URM diversity to addiction science we propose to leverage existing genetics, genomics and addiction-related research resources at The Jackson Laboratory to provide foundational education and onsite hands-on training through mentorship of URM student-faculty teams.